Understanding the mechanisms of ESX secretion systems in mycobacteria

PROJECT SUMMARY
Mycobacterium tuberculosis is the causative agent of tuberculosis, a disease that takes the lives of millions of
people annually. With the rise of multidrug resistant mycobacteria there is a dire need for development of new
antibiotics and therapies. The ESX-3 secretion system is an attractive target, as it is required for the selection
and release of various M. tuberculosis substrates and is required for iron acquisition and homeostasis. This latter
role is essential in M. tuberculosis, such that if ESX-3 is knocked out the bacteria will not survive in vitro without
excess iron supplementation. Development of a new therapeutic, such as a small molecule that prevents the
secretion mechanism underpinning the function of the complex, requires an understanding of the ESX-3
structure. The Rosenberg lab has determined the structure of the model organism M. smegmatis ESX-3
secretion system using cryo-electron microscopy. M. smegmatis is a nonpathogenic, fast growing
mycobacterium that expresses ESX proteins homologous to M. mycobacterium. The cryo-EM structure has
provided novel insight into how ESX-3 complexes oligomerize, as well as how the individual components that
comprise the ESX-3 complex interact with one another. Based on our structure, which we believe is the complex
trapped in the "off" state, I hypothesize that substrate secretion through ESX-3 is modulated by changes in the
molecular configuration of the machine. In Aim 1, I will use a combination of mycobacterial genetics, structural
biology, and cryo-EM to trap the ESX-3 complex in an alternative, active state that will inform how the complex
rearranges during secretion. In Aim 2, I will use deep mutational scanning and a survival assay I developed to
further investigate the importance and function of the core ESX-3 proteins using the previously mentioned low-
iron growth phenotype, where if an essential protein, protein domain, or protein residue is mutated, the bacteria
will not survive in chelated iron media. Taken together, these aims will allow me to study the ESX-3 secretion
mechanism and determine which intra-complex interactions are required to facilitate this mechanism. These
studies may identify new targets to develop novel antibiotics and might also provide a better understanding of
the cell biology of mycobacteria.

Public health relevance
PROJECT NARRATIVE Mycobacterium tuberculosis is the causative agent of tuberculosis, the leading cause of death from a single infectious agent and which infected over 10 million people in 2016 (WHO). This grant seeks to investigate the ESX-3 secretion complex, which is conserved across mycobacteria and is required for pathogen virulence and survival during infection. Elucidating the roles of the members of ESX membrane protein complex will both further our knowledge of mycobacterial cell biology and allow us to discover molecular vulnerabilities in mycobacteria that would be amenable to targeting with antibiotics for better treatment.